Pellino1 as a regulator of antiviral immunity in the epidermis

SUMMARY
Most adults are latently infected with at least one of the two herpes simplex viruses HSV-1 or HSV-2. Upon
reactivation these viruses can cause painful skin and mucosal lesions. Numerous patient populations with
compromised immune systems or skin barrier function are at risk of frequent or severe disease and thus
greatly diminished quality of life. Atopic dermatitis is the most common chronic inflammatory skin condition and
is associated with diminish antiviral immunity in the skin through mechanisms that are poorly understood. Drug
resistant HSV strains can develop especially in transplant patients. Thus, there continue to be a need for
improved treatment strategies that encompass the host immune status.
IL-1 and IL-36 are pleotropic cytokines that can promote innate and adaptive immune responses. We
recently demonstrated that both IL-1 and IL-36 play important roles in limiting disease severity in a mouse
model of reactivation-like disease caused by HSV-1. Pellino1 (Peli1) is a ubiquitin ligase involved in IL-1/IL-36
and TLR signaling. Studies of RNA viruses in vivo have generated diverging conclusions regarding beneficial
and detrimental functions of Pellino1. Using our previously established infection model, we find that HSV-1, a
DNA virus, causes greater mortality and larger lesions in Pellino1 knockout mice than wild type. In Peli1-/- mice,
the virus disseminates rapidly through the skin epidermis and hair follicles; thus, Pellino1 clearly has one or
more protective immune functions in keratinocytes and the epidermis. RNA-seq analyses revealed surprising
mechanistic insight. Our newly developed hypotheses will be tested in keratinocyte specific conditional
knockout mice using the established mouse infection model. Further validation of concepts will be obtained
through use of human and mouse conventional and organoid-like cell cultures. We will define how the studied
mechanisms may limit viral replication in keratinocytes by preventing, for example, cellular entry and exit of
mature viral particles. Improved insight into these antiviral mechanisms may underpin future research into
immune dysfunction and drug development aimed at alleviating severe and/or persistent disease in at risk
patient populations.

Public health relevance
NARRATIVE Viral skin infections cause diminished quality of life, can become life-threatening, and disproportionally affect patients with atopic dermatitis and a compromised immune system. Pellino1 is a ubiquitin ligase involved in immune signaling pathways and will here be examined as a regulator of innate antiviral immunity in the skin. Identification of innate immune mechanisms aimed at restricting viruses will further our understanding of how the immune system works and form the foundation for future studies into medical conditions in which the immune system fails.